2/2 CSUF/UCI-CFCCC Cancer Health Equity Research Partnership (CHERP)

CSUF/UCI-CFCCC Cancer Health Disparities Research Program (CHERP)
Administrative Core: Abstract
The overall goal of the administrative core is to provide oversight to all administrative, fiscal, and
communication/partnership needs for the P20 collaboration between the California State University, Fullerton
(CSUF) and the University of California, Irvine, Chao Family Comprehensive Cancer Center (UCI-CFCCC). The
specific aims are the same as the overall component, and include the following: to plan, implement and evaluate
a highly integrated and interactive cancer health disparities partnership between CSUF and UCI-CFCCC; to
conduct pilot cancer health disparities research projects involving at least one investigator at each institution that
advance knowledge regarding cancer health disparities, leading to the submission of competitive grant
applications by NIH/NCI and other federal/non-federal agencies; and to provide cancer research education to
underrepresented undergraduate and graduate students to increase their understanding of cancer health
disparities, leading to a larger pool of highly talented future scientists from diverse backgrounds.
To accomplish this we will undertake a set of activities organized under four components. The Adminstrative
Core will be responsible for the overall administrative and fiscal aspects of all P20 activities, and will include the
Executive Committee and Internal Advisory Committee. Activities will be implemented in three stages: initial
planning, implementation, and evaluation. The evaluation effort will be spearheaded by an external evaluator
with expertise in multi-component center reviews. The long term goals of this collaborative partnership are to
diversity the cancer research workforce and ultimately increase our scientific impact to address the cancer health
disparity needs of the large geographic areas between CSUF and UCI-CFCCC that comprise the cancer center's
catchment area.